A molecular investigation of retinoic acid-dependent homeostatic synaptic plasticity

Principal Investigator: Chen, Lu
Summary
Our research focuses on uncovering the molecular mechanisms of a form of non-Hebbian synaptic
plasticity, namely homeostatic synaptic plasticity. In contrast to the self-reinforcing nature of Hebbian plasticity,
homeostatic plasticity operates under different rules as a “corrective” mechanism to prevent run-away Hebbian
plasticity. Compared to Hebbian plasticity, the molecular and cellular mechanisms underlying homeostatic
synaptic plasticity is much less understood, and their implication in neuropsychiatric disorders is largely
unexplored. Work from our labs in the past years show that retinoic acid (RA) signaling, a major signaling
pathway mediating homeostatic synaptic plasticity, is severely impaired in the absence of FMRP expression,
resulting in a lack of homeostatic plasticity in both mouse and human FXS neurons. Moreover, we demonstrate
that under a more natural, enriched environment, compromised homeostatic synaptic plasticity in adult mice
induces run away Hebbian plasticity as manifested by greatly enhanced LTP and diminished LTD. As a
behavioral consequence, animals with defective homeostatic plasticity exhibit enhanced learning but reduced
behavioral flexibility when raised in enriched environment. Together, our work establishes a link between
synaptic RA signaling, homeostatic plasticity and cognitive function, and suggests that impaired homeostatic
plasticity may contribute to cognitive deficits in FXS. The goal of the proposed research project is to gain further
understanding of the molecular and cellular mechanisms of RA-dependent homeostatic plasticity. Specifically,
we will focus on three aspects of RA signaling in the context of homeostatic synaptic plasticity: the trans-synaptic
cell adhesion molecule neurexins, the BDNF-TrkB retrograde signaling, and the functional interaction between
FMRP and RA receptor RARα. Together, results from this proposed study will identify new candidate molecular
tools for investigating in vivo function of homeostatic synaptic plasticity, and also provide insight into discovering
new drug targets for treating FXS and potentially other mental disorders.
Relevance
This project will investigate molecular mechanisms through which synaptic RA signaling regulates synaptic
strength in a homeostatic manner. Recent studies using FXS model mice and human FXS patient neurons
establish that defective RA-dependent homeostatic synaptic plasticity is a major synaptic dysfunction phenotype
associated with fragile-x syndrome. Thus, uncovering additional molecular players critically involved in
homeostatic plasticity will provide the opportunity to discover new drug targets for treating FXS and other forms
of mental illness in which circuit maladaptation due to compromised homeostatic plasticity is a major contributor
to disease symptoms.
PHS 398/2590 (Rev. 11/07) Page 1 Summary

Public health relevance
Principal Investigator: Chen, Lu Project Narrative This application proposes to use state-of-art genetic tools to explore the molecular mechanisms of retinoic acid- mediated homeostatic plasticity in the mouse hippocampal neurons. In identifying molecular players involved in different cellular events of synaptic RA signaling, this application will contribute to a better understanding of the synaptic and circuit underpinning of mental illness. PHS 398/2590 (Rev. 11/07) Page 1 Project Narrative